NINDS CENTER FOR CLINICAL RESEARCH

This modification supports the Parkinson's Disease common data elements (CDE) project. The Parkinson's Disease CDEs support researchers engaged in research on Parkinson's Disease to align research data collection to allow for greater collaboration and sharing.

The contractor provides support for the ongoing maintenance and updating of existing disease-specific and core sets of CDEs. The contractor collaborates with NINDS to oversee the maintenance and updating of the current CDE database and knowledgebase.